Institutional Career Development Core

SUMMARY KL2
There is an emerging workforce crisis in the number of scientists entering translational research careers. This
shortage is occurring against the backdrop of increasing complexity in modern scientific research, where single
discipline research studies simply cannot answer the challenges that face modern medicine today. The ever-
growing complexity of 21st century translational science requires transdisciplinary (TD) team-based
research that integrates and extends beyond discipline-specific concepts, approaches, and methods to
accelerate the innovations that will solve complex real-world problems. The NCATS KL2 career development
program is a key initiative designed to maintain and expand the pipeline of innovative, collaborative and
productive clinical-translational scientists though implementation of customized individual development plans
(IDPs), TD mentoring, and individualized curricula. Our goal is to develop a cohort of TD scientists who have
the breadth and depth of skills necessary to navigate the critical future issues of health and disease in our
increasingly complex world. In our newly envisaged ConduITS career development program, we will focus on
training TD clinical translational research data scientists. The KL2 scholars will be trained in core competencies
including epidemiology, study design, biostatistics/data science, informatics, clinical trials, and
ethical/regulatory guidelines, as well as have broad exposure to the methodological steps of the translational
process from discovery to community engagement via innovation, life course research, and workforce
development. Moreover, we focus on training team-based clinical and translational researchers by leveraging
our rich research environment of large-scale clinical datasets, well-established cohorts and biobanks, such as
the BioMe Biobank and the Environmental Influences on Child Health Outcomes (ECHO) cohort among other
big data resources. Our state of the art programs in genomics and exposomics, and strong community
engagement have helped Mount Sinai develop a number of highly innovative programs in drug discovery,
entrepreneurship, and team-building, bringing together biomedical research stakeholders that reflect scientific
expertise across the lifespan. Our workshops, short courses and advanced training seminars focus on strategic
areas, such as informatics, big data, workforce development, team science, and community engagement, as
well as academic skills including scientific writing, negotiation skills, conflict resolution, industry interactions,
federal grant preparation and management, and the promotion process. We also offer a mentor training
program aimed to teach mentors the skills that will help improve the mentoring experience, promote mentees’
growth and help build resilience and confidence. Furthermore, to provide our younger generation of scientists
networking opportunities, we are building an institutional K-Club of successful junior faculty with career
development grants, to serve as a communication hub for various career development activities. Finally, we
partner with the Office of Diversity and Inclusion to promote a more diverse cohort of KL2 scholars.